Prenatal endocrine-disrupting chemicals, pandemic-related stress and social risk in mothers and infants

Project Summary
Mother-infant (M-I) interaction sets the behavioral foundation and trajectory for infant social/cognitive
development. Parental social behaviors are vulnerable to endocrine-disrupting chemicals because these
behaviors are shaped by hormonal priming and the organization of the social/parental brain. In utero bisphenol
A (BPA) exposure disrupts maternal care and offspring social behavior/neurobehavioral development in animals
and humans. To date, the effects of BPA on M-I interaction have not been examined, one aim of our ongoing
R01 ES027424. Although BPA has been removed from many consumer products, it has been replaced by
structural analogs, bisphenol-s (BPS) and bisphenol-f (BPF), which may have similar detrimental effects. This
study aims to translate findings from animal models to ask whether increased prenatal BPA, BPS, BPF (BP)
exposure in humans predicts less optimal M-I interaction. Understanding the effects of BP on M-I interaction is
essential to revealing pathways through which BP may act to disrupt neurodevelopment. We recruit women
during pregnancy, assess prenatal BP exposure using multiple urine samples from the 3rd trimester of pregnancy,
and assess M-I interaction with measures of sec-by-sec reciprocal M-I influences, providing a nuanced measure
of the effects of BP. The COVID-19 pandemic hit NYC in March 2020, exposing new mothers to high levels of
additional stress: sudden onset, world-wide impact; high death rates/levels of fear; disproportionate impact on
racial/ ethnic minorities; hardships e.g. social isolation, job loss, social distancing/wearing masks, exacerbated
postpartum mental health difficulties (pandemic-related stressors). Stress exacerbates the effects of chemical
exposures on child health outcomes, highlighting the need to consider the impact of these additional pandemic-
related stressors which may lead to pandemic-related stress (symptoms consistent with DSM-5 acute stress
disorder diagnosis). In our existing R01 ES027424, data collection was halted by the pandemic and has now
resumed, providing a unique opportunity and an imperative to study whether pandemic-related stress(ors) alter
the association between bisphenol exposure and M-I interaction. This time-sensitive R21 collects and analyzes
information aimed to determine (a) whether the social exposure of living through the pandemic alters M-I
interaction, and/or alters the effects of bisphenol on M-I interaction; and (b) within the pandemic-exposed group,
whether higher COVID-19 pandemic-related stress(ors) alters bisphenol exposure, and/or alters M-I interaction.
Understanding how pandemic-related stress(ors) may impact M-I interaction and/or exacerbate the effects of
environmental exposures on M-I interaction is essential to (i) informing clinical intervention: stress is modifiable,
a potential target of public health intervention; (ii) revealing one developmental pathway through which the
COVID-19 pandemic may disrupt child development, and (iii) informing medical/ public health policies in future
pandemics.

Public health relevance
PROJECT NARRATIVE Mother-infant interaction predicts child social/ cognitive development and has a lifelong impact. Understanding how pandemic-related stress(ors) may impact mother-infant interaction and/or exacerbate the effects of environmental exposures on M-I is essential to (i) informing clinical intervention, as stress is a modifiable factor that can be the target of public health intervention; (ii) revealing one developmental pathway through which the COVID-19 pandemic may disrupt child development, and (iii) and informing medical and public health policies in future pandemics.